Determinants of reservoir contraction and expansion in vivo, ex vivo, and in vitro

The advent of antiviral therapy (ART) led to decreased morbidity and mortality among individuals with HIV by
reducing viral loads to undetectable levels. It also revealed a treatment resistant reservoir. Infected CD4+ T
cells are the major contributor to that reservoir and are a source of recurrent viremia when ART is stopped. Our
long-term goal is to dissect the contraction and expansion forces exerted on the persistent HIV reservoir by
performing parallel sequencing experiments in resting CD4+ T cells in vivo, ex vivo, and in vitro.
We were motivated to monitor the HIV reservoir by proviral sequencing 1-6 to overcome the erroneous HIV DNA
estimates that are dominated by defective proviruses. We first monitored reservoir dynamics in individuals
treated during chronic infection using a sequencing approach that estimates reservoir size by multiplying the
level of total HIV DNA by the frequency of intact proviruses 5. To capture a spectrum of immune responses we
expanded our cohort to include those treated during acute infection or those treated while demonstrating elite
control. An important advantage of utilizing sequencing to estimate reservoirs over other approaches is the
ability to identify large proviral clones (or repeated sequences). By removing large proviral clones from our
analysis we could provide a better estimate of inherent decay. Moreover, analyzing the repeated sequences
alone provides an estimate of clonal expansion.
While many in the field are studying the role of antigen and homeostatic cytokines on clonal expansion 7-9 we
focus on changes in the genetic makeup of the provirus as we noticed specific viral elements were enriched in
proviral clones (Fig. 3, blue D1-D4+,4). This observation led to the development of a machine learning
approach that analyzes viral elements systematically overtime, without bias, to define genetic elements that
promote reservoir contraction or expansion. Similarly, we will identify interactions between elements. In Fig. 12,
we show the results of our machine learning analysis which revealed a role for D1 in reservoir decay, Nef for
immune protection and Tat for clonal expansion 10.

Public health relevance
RELEVANCE (See instructions): Our proposal studies why HIV reservoirs decay at different rates in various cohorts of HIV-infected individuals on antiviral therapy. We hypothesize that reservoir contraction and expansion occur simultaneously in all HIV-infected individuals making the reservoir appear stable. We propose to perturb these forces and use a machine learning analysis to identify the drivers behind them and to ultimately reduce the size of the HIV reservoir.